Defining Therapeutic Sensitivity of Patient-Derived Cancer Organoids in Cholangiocarcinoma

Candidate: I am a staff medical oncologist at the William S. Middleton Memorial Veterans Hospital and Assistant
Professor of Medicine at the University of Wisconsin School of Medicine and Public Health. I obtained my MD
from the University of Michigan and American Board of Internal Medicine research fast track in internal medicine
and medical oncology at the University of Wisconsin. I completed my post-doctoral training with Dr. Dustin
Deming to study mechanisms of targeted therapeutic resistance in colorectal cancer organoid models. I currently
serve as subject matter expert in gastrointestinal cancers with the VA National Precision Oncology Program. My
goal is to develop an independent research program specific to hepatobiliary cancers to improve the health
outcomes of Veterans through precision applications informed from organotypic models. I was recruited to the
William S. Middleton Memorial Veterans Hospital and the University of Wisconsin with support of clinical and
research efforts dedicated to building our research program through institutional mentorship, laboratory
resources, and start-up funding.
Research Project: Cholangiocarcinoma (CCA) represents a leading cause cancer-related mortality with 5 year
survival estimated <10% in the United States. Patient-derived organoid models have improved pre-clinical
modeling of gastrointestinal cancers. There remains a significant unmet need to standardize these models in
CCA with a critical gap in knowledge to understand if these models can predict clinical outcomes. Chemotherapy
is standard in clinical management for advanced CCA, however therapeutic resistance is universal for advanced
disease. We propose a dedicated investigation of organoid modeling under therapeutic treatment for the
prediction of clinical response. Cyclin-dependent kinase 7 (CDK7) functions as a key regulator of RNA
polymerase II is overexpressed in nearly 40% of CCA. It has recently been shown to have activity using historic
2D models of CCA as monotherapy. Here, we present a dedicated assessment of CDK7 targeting in response
to DNA damaging chemotherapy in CCA. Using models stratified by key mediators of cell cycle and homologous
DNA damage, we propose to quantitate therapeutic response. We aim to understand the fundamental
mechanisms specific to response by characterizing DNA damage, cell cycle arrest and the inhibition of RNA
polymerase II. Our central hypothesis is that the sensitivity of CCA organoids will predict prospective
clinical outcomes and that CDK7 inhibition (CDK7i) will improve sensitivity to chemotherapy-induced
DNA damage as a lead therapeutic combination from patient-derived models. We will investigate this
hypothesis with three specific aims. Specific Aim 1: Quantify the effect of CDK7i on cell cycle propagation,
activation of RNA polymerase II, and DNA damage repair in CCA organoid models. Specific Aim 2: Validate
the response of CCA organoids to chemotherapy as predictive of clinical outcomes. Specific Aim 3: Evaluate
activity of CDK7i in combination with chemotherapy in patient-derived xenograft (PDX) models of CCA.
Career Plan: My long-term career goal is to become an independently funded VA physician-scientist who is a
leader in the field of treating gastrointestinal malignancy by targeting shared mechanisms of transcription-
mediated resistance. My primary VA research mentor, Dr. Mark Albertini, will guide my progress and training.
My additional mentors and collaborators will provide the training to accomplish my research aims and career
goals and further my knowledge of cancer stem cell modeling and liver cancer biology. The results from this
CDA-2 will provide me with the preliminary data and research experience to formulate a competitive MERIT
Review proposal to further develop novel therapeutic targets for hepatobiliary cancers.
Environment: I will complete the proposed research at the Madison VA and the University of Wisconsin. Both
organizations provide an exceptionally collegial atmosphere and strong institutional support that include
complementary laboratory resources, equipment, and core facilities.

Public health relevance
Veterans are at increased risk for cholangiocarcinoma (CCA)—a type of liver cancer—due to their advanced age and increased incidence of hepatitis C virus and chronic liver disease. Despite the use of systemic chemotherapy, CCA is deadly with a 5-year survival of 10% in the advanced setting. Recent work has defined distinct molecular subtypes of CCA, however tuning precision strategies for an individual remains limited to a few select biomarkers and chemotherapy remains a standard of care, despite significant clinical toxicities. I hypothesize that cyclin-dependent kinase 7 (CDK7) regulates response to DNA damage after chemotherapy in patient-derived organoid and xenograft models of CCA. By characterizing the mechanism of this response in combination with chemotherapy, we can develop biologically informed combination therapy. Together, this project utilizes human models of CCA to better understand both therapeutic sensitivities and resistance mechanisms to inform rational strategies to improve the survival of Veterans with this devastating disease.